Enhancing the Survival of Low Birth Weight Infants in Low Resource Settings using an Implementation Science Approach

PROJECT SUMMARY
Globally, about 20 million infants are born with low birthweight (LBW), and these infants face a myriad of health
challenges, including difficulties in regulating body temperature, poor nutritional outcomes, increased
vulnerability to infections, and delayed development, placing emotional and financial burdens on families.
Kangaroo Care (KC), consisting of continuous skin-to-skin contact, exclusive breastfeeding, and early discharge,
is an evidence-based intervention recommended for LBW newborns to improve their survival and healthy
development, especially in low-resource settings where the risks of prematurity, neonatal hypothermia, and
neonatal mortality are disproportionately high. Despite the effectiveness of KC, widespread scale-up has been
slow due to barriers to implementation and adoption. Existing efforts have primarily focused on health systems
and policy changes, neglecting the need to support mothers and families to continue practicing KC at home.
Several sociocultural and economic factors, including lack of essential warmth-related items, cultural norms,
stigma, and limited social support, hinder the KC continuation at home. To address these challenges, we have
developed an intervention grounded in the Information, Motivation, and Behavior (IMB) model. The intervention
offers emotional, informational, and motivational peer support to mothers of LBW infants and a kit containing
low-cost, locally sourced neonatal care items to facilitate skin-to-skin contact and breastfeeding. Guided by the
Consolidated Framework for Implementation Research (CFIR) and the Reach, Effectiveness, Adoption,
Implementation, and Maintenance (RE-AIM) framework, we will conduct a type II hybrid effectiveness-
implementation study. First, we test the effectiveness of our intervention using an individual randomized
controlled trial, enrolling 328 mother-infant dyads eligible for KC from two tertiary hospitals in Ghana (Aim 1). We
hypothesize that mothers receiving the intervention will be more likely to continue KC at home 7 days after
discharge compared to those in the control group receiving the standard of care. Our primary effectiveness
outcome is any duration of skin-to-skin contact and exclusive breastfeeding at 7 days post-discharge. Second,
we will explore the implementation process including associated barriers and facilitators to implementation, using
mixed methods (Aim 2). In-depth interviews will be conducted with participants, peer supporters and healthcare
workers. Thematic analysis of the interviews will be guided by the CFIR framework and combine both inductive
and deductive approaches. Findings from this research will inform the development of effective models for KC
implementation and scale-up.

Public health relevance
PROJECT NARRATIVE Improving the survival and healthy development of low birthweight infants is an urgent global priority, especially in low-resource settings where the risks of prematurity, neonatal hypothermia, and neonatal mortality are high. This proposal seeks to address this issue by evaluating whether offering mothers of low birth weight infants emotional, informational, and motivational support through peers and material support with a package of neonatal care related items is an effective strategy for increasing kangaroo care at home. Findings hold the potential to not only advance neonatal care in low-resource settings but may also be relevant to underserved populations in high-income countries similarly facing a high risk of neonatal mortality.